Development and validation of patient-ready Callascope for cervical imaging

Cytology-based screening, diagnostic colposcopy and excisional treatment are proven solutions for cervical
cancer prevention in high-income countries (HICs). Affordable tools for screening, diagnosis, and treatment in
low- and middle-income countries (LMICs) are either lacking or the few health facilities with access to them are
frequently out of reach; resulting in low screening and follow up rates. Vaccination does not benefit the millions
of women who already have the Human Papilloma Virus (HPV) or who will contract it before vaccination is widely
available. As a result, women present with advanced disease untreatable by currently available modalities,
leading to over 300,000 deaths each year. The number of expected deaths will continue to increase and is
expected to double by 2050. These facts are sobering - another generation of women will die at the prime of
their lives, devastating their families and their children’s health. We have developed a robust health care model
to resolve the incongruity between highly effective biomedical engineering solutions and their uptake into care
delivery systems for global cervical cancer prevention. There are three facets to our model: (1) Technology: a
suite of point of care solutions to provide screening, diagnosis and treatment alternatives to those used in high-
resource settings, (2) Community-based health care: community-based clinics in which screening, diagnosis and
treatment are provided community health workers and midwives, and (3) Communication: a virtual hub to link
community health workers, midwives and physicians to ensure seamless continuum of care. The key attribute
of our model is that it shifts care from hospitals and physicians to community health workers and midwives
dramatically increasing access to care. We have observed that access continues to be a problem, one that is
observed globally by implementers and program planners. This is related to both population and health
infrastructure barriers. The inability of certain segments of the population to visit a clinic includes but is not limited
to the lack of resources, geographic barriers that make it challenging to reach a clinic, and the trepidation of
receiving the exam in an unfamiliar environment. Barriers related to health resources include lack of sufficient
health providers, limited medical supplies, and the unavailability of administrative support, and medical record
keeping. There is a critical need for solutions to address uneven access to care even when health care delivery
is decentralized from hospitals to communities, therefore, we propose an innovative technology called the
Callascope to transform provider-controlled speculum-based imaging in a clinic to a patient-controlled self-
imaging procedure at home that affords privacy and autonomy of an otherwise intrusive exam. Our long-term
goal is to develop a fully functional Callascope that meets the requirements for triage of screen-positive
populations (women who are HPV positive). Given the low prevalence of disease, this will reduce unnecessary
clinic visits by 20-fold (50 out of every 1000 women) thereby allowing for efficient use of limited resources for
high-risk populations and alleviating the burden of follow up care to those who are at low-risk.

Public health relevance
Project Narrative Cervical cancer is a disease of disparity, predominantly impacting women in low- and middle-income countries. The World Health Organization has issued a call to action to implement new screening methods to eliminate cervical cancer in the next 100 years. Calla Health Foundation will develop a speculum-free technology, the Callascope to shift provider-controlled imaging in the clinic to women-controlled imaging at home, which will increase access to cervical cancer detection by reducing social and structural barriers that make clinics out of reach.